Universal Internal Standard for Reproducible Accurate Quantification of Exosome Protein Markers

Abstract: Pancreatic cancer is currently the third leading cause of cancer related to death in the USA with a 5-
year survival rate of <5%. Most potentially curable patients present with unresectable locally advanced
disease where the standard of care includes a combination of chemotherapy and radiation therapy. A major
challenge in the management of pancreatic cancer is the early assessment of treatment response. Novel
markers of early treatment response are critically needed to make better informed decisions regarding the type
and sequencing of therapies, given the high toxicity associated with these treatments. In our previous work we
were able to identify 20+ exosomal protein markers from the serum of patients with locally advanced pancreatic
cancer during therapeutic treatment by using exosome isolation methods and mass spectrometry analysis.
However, such analysis for large clinical cohorts was limited by the reproducibility in exosome preparation for
accurate quantification of exosomal proteins, which is a significant problem in the exosome omics research field.
In the current proposal, we plan to develop the analytics of exosome isolation and characterization with a focus
on rigor and reproducibility. We will develop a super-SILAC-based (Stable Isotope Labeling by/with Amino
acids in Cell culture) exosome method as a universal internal standard (UIS). In principle, when the super-SILAC-
based exosome is spiked into human serum for proteomic analysis it can follow the same experimental workflow
as serum exosomes which could maximally reduce variations introduced by sample preparation and LC-MS
(Liquid Chromatography-Mass Spec) analysis. Therefore, SILAC-labeled exosomes will be ideal with a dual
function for biomarker analysis for reproducible sample preparation and acting as a UIS. Targeted LC-SRM and
PRISM-SRM exosome analyses of markers from our prior studies will be used with the UIS to precisely monitor
changes in proteins during a course of chemo-radiation therapy. Patients with locally advanced pancreatic
cancer will undergo serial blood draws prior to, during, and after treatment with chemotherapy followed by
chemo-radiation. We will then perform a targeted proteomics confirmation study based on exosome markers
identified in our previous work that have a specific response to a course of chemo-radiation therapy. The marker
value changes compared to baseline will be associated with the treatment outcomes (such as progression-free
survival and overall survival) in patients. This work will establish the potential use and measurement
reproducibility of these exosomal markers for monitoring changes in protein markers during and after treatment.
The LC-SRM mass spec-based assay to be used herein has the distinct advantage of being multiplexed for over
20 markers simultaneously. The proposed work contains several novel aspects including: 1) the use of super-
SILAC to address irreproducibility in accurate quantification of exosome proteins especially for multi-step
exosome preparation and 2) multiplexed targeted LC-SRM and highly sensitive PRISM-SRM assays for
biomarker analysis in patient serum exosomes.

Public health relevance
Narrative: Tumors release microvesicles called exosomes that reflect the protein content of the tumor itself. We will develop methods using a universal internal standard(UIS) for highly reproducible quantitative analysis of the protein content of exosomes from patient serum during a course of treatment with chemotherapy and radiation therapy. This method will be applied to a set of exosome protein markers from prior work for monitoring changes in protein cargo after treatment via a targeted mass spec-based approach.